Estimates of Resident Population for Counties

To develop the following four products of estimates of resident population for counties:

1a. Vintage 2020 estimates - county population estimates by single year of age (0-84), sex, bridged race, and Hispanic origin for April 1, 2010 (estimates base) and annually July 1, 2010-2020 developed using updated race-bridging probabilities provided to the Census Bureau by the National Cancer Institute.

1b. Vintage 2020 estimates - county population estimates by age group (85-89, 90-94, 95-99, 100+), sex, bridged race, and Hispanic origin for April 1, 2010 (estimates base) and annually July 1, 2010-2020 developed using updated race-bridging probabilities provided to the Census Bureau by the National Cancer Institute.

2a. Vintage 2021 estimates - county population estimates by single year of age (0-84), sex, bridged race, and Hispanic origin for April 1, 2020 (estimates base) and annually July 1, 2020-2021.

2b. Vintage 2021 estimates - county population estimates by age group (85-89, 90-94, 95-99, 100+), sex, bridged race, and Hispanic origin for April 1, 2020 (estimates base) and annually July 1, 2020-2021.